Target Validation Core

Project Summary/Abstract: Target Validation Core (Core 3)
With the explosion of new technologies, biomedical research has been moving at a very fast pace in
generating novel links and suggesting promising therapeutic avenues. The research proposed in the MTDD
COBRE application is expected to identify a number of exciting molecular targets. However, before further
efforts and resources are devoted to these targets, it is crucial to have validation for physiological relevance
and functional significance. With the common goal of achieving target validation, we propose to establish two
key resources at UNMC, the Genome Editing facility and the Mouse Model and Imaging facility. Together,
these facilities will comprise the Nebraska Center for Molecular Target Discovery and Development Target
Validation Core.
The newly developed genomic editing technology, CRISPR, allows researchers to examine the relevance of
their target proteins or processes in a clean genetic background within a significantly shorter time frame. As
we have accumulated extensive experience in the CRISPR technology, we propose to establish a core facility
to provide the MTDD researchers with knockout or knockin cell lines for their genes of interest, thus allowing
them to validate their findings in a reliable and efficient fashion.
Another essential component of target validation is to determine the effect(s) of novel genetic,
pharmacological, and environmental interventions on patient outcome. Mouse orthotopic xenograft models are
ideal systems for the initial assessment of the impact of clinical interventions on disease outcome. To support
the studies proposed in the MTDD COBRE application, we propose a core facility, which will focus on mouse
models and feature state-of-art, advanced imaging capabilities to detect and monitor tumor development and
progression non-invasively and effectively. Investigators with access to this core service will thus be better
poised to understand the functional impact of specific genetic and pharmacologic interventions. Additional core
strengths will include mouse metabolic assessment (by indirect calorimetry).
The Core co-leaders have many years of experience in the field. Core staff are highly trained. We propose to
ensure rigorous core quality at both an experimental (operator training and formalized equipment maintenance)
and a systematic (input resulting from an annual external advisory board meeting) level. Together, the Target
Validation Core is expected to provide the necessary technical input in target validation, and support MTDD
investigators in achieving their goal of conducting high-impact research.